Development Therapeutics Branch Clinical Trials

We focus on drugs targeting the genome, especially novel topoisomerase inhibitors as single agents and in combination with DNA repair and immune checkpoint inhibitors. One of our topoisomerase I (TOP1) inhibitors, LMP400 (Indotecan) finished Phase 1 clinical trials. Another (LMP776, Indimitecan) is finishing phase 1 and LMP744 is in phase 1. We have clinical trials with tumor-targeted TOP1 inhibitors (Onivyde, CRLX101, PLX-038 and PEN-866), and clinical trials with combination of TOP1 inhibitors with poly(ADPribose)polymerase (PARP1/2) and immune checkpoint inhibitors. Our ongoing clinical trials include: (NCI protocol #PITrial nameCancer Phase) 15-c-0150, Thomas, ATR inhibitor plus topotecan, Small cell lung cancer and extrapulmonary cancer, Phase II; 16-c-0107, Thomas, Nanoparticle campto plus olaparib, small cell lung cancer, prostate cancer, bladder cancer, Phase II; 17-c-0012, Thomas, Liposomal irinotecan plus veliparib, solid tumors, Phase I; 17-C-0117, Thomas, Hsp90-SN39 conjugate, Solid tumors, Phase I; 15-c-1045, Lee, Durvalumab plus olaparib, small cell lung cancer, Phase II; 18-C-0110, Thomas, PD-L1/TGFB antibody plus temozolomide, small cell lung cancer, Phase II. The clinical trials openings in 2019 include: (TrialCancerPhase) PEG-SN38 plus rucaparib, solid tumors, Phase I; LMP400 plus olaparib HRD, solid tumors, Phase I; Durvalumab plus olaparib, EGFR-transformed small cell lung cancer, Phase II; ATR inhibitor plus topotecan, small cell lung cancer and extrapulmonary cancers, Randomized Phase II.